The UNC Chapel Hill Superfund Research Program (UNC-SRP)

PROJECT DESCRIPTION
Summary: While prenatal exposure to environmental metals, such as inorganic arsenic, is
associated with decreased gestational age, there is a fundamental knowledge gap regarding the
placental molecular drivers of this association. Numerous epidemiological studies have
associated exposure to individual environmental metals, such as inorganic arsenic and lead, with
decreased gestational age. Often such studies analyze chemical exposures individually instead
of in mixtures. This analytical approach does not reflect the fact that humans are exposed to
complex mixtures of environmental chemicals that may have interactive or synergistic effects.
Ignoring the possibility of these combined effects may obscure the full extent of the association
between exposure to environmental metals and gestational age. This project will examine the
association between exposure to environmental metals early in life and gestational age. The
metals will be analyzed individually as well as a mixture. Subsequently, to identify biological
mechanisms underlying this association, we will identify specific miRNAs and proteins within the
placenta that may mediate the association between metal exposure and gestational age.

Public health relevance
NARRATIVE: THE UNC-CHAPEL HILL SUPERFUND RESEARCH PROGRAM North Carolina (NC) communities are impacted by inorganic arsenic (iAs) contamination of soil and water resulting from naturally occurring and industry-derived sources. With relevance to the SRP, ATSDR and USEPA, the theme of the UNC-SRP is Identifying novel methods to reduce iAs exposure and elucidating mechanisms underlying iAs-induced metabolic dysfunction with a vision for disease prevention. With relevance to the communities in NC and the US, the UNC-SRP aims to discover biological mechanisms and susceptibility factors underlying iAs-associated metabolic dysfunction/diabetes, develop novel methods and technologies to predict iAs contamination and reduce iAs exposure, and translate the science of the UNC-SRP to key stakeholders in NC and the larger SRP program, and engage vulnerable communities.